Policy effects on gender minority health and evidence from the implementation of gender affirming coverage in Medicaid

PROJECT SUMMARY/ABSTRACT
This AHRQ Mentored Research Scientist Career Development Award (K01) will establish Dr. Alex McDowell
as a national expert in sexual and gender minority (SGM) health policy, leading health services research that
identifies policy approaches to address SGM health inequities.
With the support of this K01, Dr. McDowell will use Medicaid claims and encounter data to evaluate the impact
and implementation of gender affirming coverage policies in Medicaid, generating novel and timely evidence
that stakeholders can use to inform federal and state policies. Using the staggered introduction of gender
affirming coverage policies across states, 2016-2022, this study will employ difference-in-differences methods
to estimate the effect of these policies on use of gender affirming health care services (e.g., hormones and
surgery) among gender minority (i.e., transgender and gender diverse, GM) individuals. Given notable mental
health inequities among the GM population in the U.S. and the demonstrated link between use of gender
affirming services and improved mental health outcomes for GM individuals, Dr. McDowell will also study the
effects of adoption of gender affirming coverage policies in Medicaid on adverse mental health outcomes,
including psychiatric hospitalizations and suicidality, among GM enrollees. Lastly, Dr. McDowell will use the
Consolidated Framework for Implementation Research (CFIR) and semi-structured interviews with Medicaid
stakeholders to identify barriers and facilitators to implementation of gender affirming coverage policies in
Medicaid, including differences across Medicaid financing models (e.g., fee-for-service vs. managed care).
This project will combine rigorous quasi-experimental policy evaluation with contextual data on the barriers and
facilitators to implementation to provide a comprehensive understanding of the impact of Medicaid gender
affirming coverage policies on GM health and health care.
The proposed research builds upon and extends Dr. McDowell’s training in health services research methods
and prior research in GM health policy among commercially insured individuals. Her training plan will support
her goals of developing expertise in Medicaid financing and managed care, acquiring skills in the measurement
of gender affirming care, and gaining proficiency in implementation science research. Through the research
and training in this K01, Dr. McDowell will be prepared to lead studies that systematically evaluate the effects
and implementation of ongoing policy changes affecting GM individuals at the state and federal levels and to
be a leading expert in sexual and gender minority health policy.

Public health relevance
PROJECT NARRATIVE State and federal policymakers have increasingly expanded insurance coverage for gender affirming services, which could reduce health inequities for the nearly 2 million gender minority (i.e., transgender and gender diverse) individuals in the U.S. This study will examine the implementation of gender affirming coverage policies in Medicaid to inform ongoing policy debates regarding the adoption of such policies. Through the research and training in this Mentored Research Scientist Career Development Award, the candidate will be prepared to pursue innovative research to improve health care access and outcomes for sexual and gender minority communities.